Core 2: Biostatistics

Project Summary
The Biostatistics Core (Core C) will collaborate and provide comprehensive statistics service and infrastructure
support for clinical and pre-clinical studies to all Research Projects in the proposed Program Project Grant. In
addition, it will provide support for data management and integration, informatics, and computing, and assist
with the identification and solution of complex data tasks arising in the course of project activities. Core
members will work with project investigators across a wide spectrum of activities, encompassing formulation of
the study design, data acquisition and database management, statistical quality control, patient study
monitoring, data analysis and interpretation, abstract and manuscript preparation, and data dissemination.
Furthermore, when required by specific project, Core personnel develop and implement innovative customized
biostatistics methodologies and tools in collaboration with investigators in the P01. The Core C Resource is
housed in the Division of Biostatistics and Bioinformatics, Department of Oncology at Johns Hopkins University
School of Medicine. The Division comprises an active and committed group of biostatistics and bioinformatics
faculty, as well as non-faculty biostatisticians, bioinformaticians and IT specialists, with access to state-of-the
art methodologies and a broad range of expertise. Core members have a strong commitment to this P01,
stemming from their long-standing collaborations in the research of αRPT. All proposed Projects make use of
this Core Resource in every Aim.
The primary objective of the Core C is to guide and assist the project investigators in the design, conduct,
and analysis of the laboratory, translational, and clinical studies proposed in this P01. The program has
dedicated biostatisticians thoroughly versed in the subject matter associated with the projects, and all
projects have access to the breadth of expertise provided by Core personnel. Additionally, Core members
interact on a regular basis, and work closely with the Administrative Core A and Animal Models, Pathology
and Tissue Core (Core B) and Patient Data Core (Core D), which contributes to interactions and synergy
among the projects.

Public health relevance
Project Narrative The Biostatistics Core (Core C) serves as a centralized resource to all P01 investigators and promotes synergy across projects and resources. It enhances the abilities of projects to address key scientific questions that will lead to wide implementation of αRPT dosimetry and thereby improve survival for currently incurable cancers . The work of Core C is to provide informatics support and ensure that clinical and laboratory studies are carried out using sound designs and appropriate analysis methods in order to reach justifiable scientific conclusions.